Optimization of SHIP1 Inhibitors for the Treatment of Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is a fatal neurodegenerative condition characterized by cognitive decline, β-
amyloid (Aβ) plaques, and tau-containing neurofibrillary tangles (NFTs). Recent human genetic evidence
supports an important role for microglia in the etiology of AD. Microglia are the resident immune cells in the brain
and play important roles in maintaining neuronal health and proper immunomodulation of neighboring glial cells.
Microglia clear neurotoxins, Aβ oligomers, and Aβ plaques, and thereby mitigate an inflammatory
microenvironment that is toxic to neurons. Lower expression of TREM2, a cell surface microglial immune
receptor, and hypomorphic variants (e.g. R47H), are correlated with an increased risk of developing of AD.
Conversely, enhanced signaling downstream from TREM2 via the hypermorphic P522R variant of PLCγ2
reduces risk for AD. This human genetic evidence suggests that microglia that are more sensitive to TREM2-
mediated signaling protect against neurodegeneration. Src homology 2 domain containing inositol
polyphosphate 5-phosphatase 1 (SHIP1) is a member of the inositol polyphosphate-5-phosphatase (INPP5)
family of phosphatidylinositol phosphatases. INPP5D, the gene that encodes SHIP1, has also been identified as
a risk gene for AD. SHIP1, plays a key role regulating pathways downstream from immune receptors, including
TREM2 and FcγRIIB. SHIP1, binds immunoreceptor tyrosine-based inhibition motifs (ITIMs) where it competes
with kinases and modulates phosphatidylinositol-dependent signaling. We hypothesize that inhibition of SHIP1
will improve TREM2-mediated microglial responses to neurotoxins, and promote an overall neuroprotective
phenotype to microglial states , and thereby slow cognitive decline. Furthermore, since recently approved
disease modifying anti-Aβ antibodies depend in part on Fc receptor activation of microglia, SHIP1 inhibitors may
also be combined with anti-Aβ antibodies to improve their efficacy. To test this hypothesis, we will optimize the
potency and drug-like properties of SHIP1 inhibitors from identified chemical scaffolds (Aim 1). We will identify
the effect of SHIP1 inhibition on microglial states in mouse brain, define pharmacokinetic (PK) and
pharmacodynamic (PD) relationships, and determine the level and duration of SHIP1 inhibition required for
efficacy in a mouse model of AD (Aim 2). With an understanding of the target engagement required for efficacy,
SHIP1 inhibitors with sufficient human potency and drug-like properties will be used to develop target
engagement and translational biomarker assays for human studies (Aim 3). Collectively, these studies will
support the translation of new molecular entities into the clinic that will reduce neuroinflammation and amyloid
burden and improve cognition, thus advancing the NIH/NIA mission to develop novel therapies for AD.

Public health relevance
PROJECT NARRATIVE Although the amyloid hypothesis of Alzheimer's disease (AD) has guided drug discovery research for over 30 years, more recent human genetic evidence has identified an important role for microglia in the pathogenesis and progression of AD. This proposal aims to identify drug-like, small molecule inhibitors of SHIP1, a multifactorial signaling protein that is generally viewed as a negative regulator of microglia. Our hypothesis is that inhibition of SHIP1 during the early stages of disease will stimulate the protective functions of microglia, resulting in a resilient brain, a reduced rate of disease progression, and a slowing of cognitive decline in AD patients.